Splanchnic Nerve Modulation In Heart Failure (Splanchnic X)

PROJECT SUMMARY/ABSTRACT
Heart failure (HF) affects more than 6 million adults in the U.S. alone, with increasing prevalence. Cardiovascular
congestion with resultant limitation in physical activity is the hallmark of chronic and decompensated HF. The
current HF physiologic model suggests that congestion is the result of volume retention and, therefore, therapies
(such as diuretics) have generally been targeted at volume overload. Yet therapeutic approaches to reduce
congestion have failed to show significant benefit on clinical outcomes, potentially due to an untargeted approach
of decongestive therapies. Our preliminary work suggested a complimentary contribution of volume redistribution
to the mechanism of cardiac decompensation. We identified the splanchnic nerves as a potential therapeutic
target and showed that short-term interruption of the splanchnic nerve signaling could have favorable effects on
cardiovascular hemodynamics and symptoms.
As part of our proposal, we will: (1) Investigate the impact of prolonged splanchnic nerve blockade on the
cardiovascular system in patients with HF and reduced ejection fraction (HFrEF); (2) Visualize splanchnic nerves
using intravascular imaging tools, and demonstrate technical success of the splanchnic nerve blockade; and (3)
Define the mechanisms of action of splanchnic nerve blockade and identify congestion phenotypes that respond
favorably to splanchnic nerve blockade.
The results of the proposed scientific aims will help test the paradigm shifting hypothesis of volume redistribution
as a driver of cardiovascular congestion and functional limitations and pave the way for splanchnic nerve
blockade as a novel therapeutic approach to HF.

Public health relevance
PROJECT NARRATIVE Although cardiovascular congestion is the hallmark of heart failure our understanding of mechanisms that lead to cardiovascular congestion and potential treatment options remain limited. Supported by our recent work, cardiac congestion and decompensation could be the result of internal volume redistribution from the splanchnic vascular compartment but validation of this innovative concept and novel therapeutic intervention requires detailed physiological testing. During this project, we will test the safety and mechanisms of action of prolonged splanchnic nerve blockade on exercise performance in patients with chronic heart failure and we will learn relevant methodology in phenotyping patients with chronic heart failure.